NYS AGM Food Laboratory - Laboratory Flexible Funding Model (LFFM) (U19)

NY AGM Food Laboratory - Project Summary/Abstract:
The New York State Department of Agriculture and Markets (NY AGM) has an
expansive and robust food safety inspection program and a regulatory food safety testing
laboratory. The Food Laboratory, a division within the NY AGM, has a mission to provide expert
state of the art analytical testing in support of food safety programs in New York State. The
Food Laboratory, through food testing, provides support to the divisions of Food Safety and
Inspection and Milk Control and Dairy Services. It is the primary servicing laboratory for the New
York manufactured food regulatory program and is accredited to the ISO/IEC 17025:2017
standard and AOAC ALACC criteria. The Food Laboratory has comprehensive testing programs
for microbiological and chemical contamination in food and beverages.
If funded for the Laboratory Flexible Funding Model, the Food Laboratory will maintain
resources and personnel necessary to cover testing of more than 2,000 samples according to
the Food Laboratory Sampling Plans. The laboratory will maintain a quality management system
compliant with the managerial and technical requirements of ISO/IEC 17025 and continue to be
accredited by a recognized accreditation body. It will participate in proficiency testing or
competency exercises on an annual basis to maintain analyst competency. If funded, the
following activities will be part of Food Laboratory deliverables: participation in small-scale
method development, method validation research, and matrix extension research; participation
in related training and mentorship to other State laboratories, if requested; FERN membership
and participation in conference calls, meetings, and support of FERN activities; key personnel
will be sent to all annual LFFM Face-to-Face Meetings; quarterly summaries of all food samples
collected and analyzed under the Sampling Plans, notification of FDA project manager and
technical lead of any presumptive positive samples in a timely manner, full laboratory packages
of any violative sample after laboratory report is released in a timely manner, maintenance of a
confidentiality agreement with FDA, outline plans for capacity/capability development and
special projects, and participation in at least one FDA requested assignment annually related to
human and animal food. The Food Laboratory will support the integrated food safety system by
sharing laboratory results with the FDA when considering enforcement actions for surveillance
and regulatory purposes. The laboratory is also supporting FDA's initiative to expand laboratory
testing capacity when new technologies or procedures are available.

Public health relevance
NY AGM Division of Food Laboratory Project Narrative: The New York State Department of Agriculture and Markets (NY AGM) has a comprehensive food safety inspection program and regulatory food safety testing laboratory. The Division of Food Laboratory is willing and able to engage with the national food safety system initiative by (1) participating in, and passing, annual chemistry and microbiology food related proficiency tests offered through a suitable proficiency testing program; (2) participating in small-scale chemistry and microbiology food testing related method development, method validation research, and matrix extension research, as requested by the FDA; (3) providing chemistry and microbiology food testing related training and mentorship to other state laboratories, as requested; (4) continuing to be a FERN member; (5) participating in annual LFFM face-to-face meeting; (6) maintaining ISO/IEC 17025 accreditation to ensure quality assurance and quality control testing; (7) maintaining laboratory facilities and personnel necessary to complete regulatory activities; (8) providing notifications, summaries and reports to FDA, as requested and required; (9) engaging NY AGM inspectors to collect regulatory food samples and ensure they maintain best practices when sampling FDA food regulatory products; (10) notifying the FDA project manager and the technical lead within one (1) business day of any presumptive positive or “cannot rule out” (CRO) food samples, (11) submitting a full laboratory package for any confirmed positive or violative food sample, as required; (12) maintaining a confidentiality agreement with FDA as a valid 20.88; (13) participating annually in at least one FDA requested assignment related to food testing; (14) providing an outline plan on how the laboratory will sequence genomes and upload data in real-time to NCBI-NIH curated national database for enteric pathogens; and (15) providing outline plans for Chemistry and Microbiology Capability/Capacity Development and for Special Projects (Sample Collection, NFSDX and ORAPP Integration, and Method Development/Validation).